Leveraging Embedded Mobile Device Sensors for Detection of Children's Mobile Screen Use: Examining Feasibility and Performance

PROJECT SUMMARY/ABSRACT
Measuring mobile screen use accurately has proven difficult due to limitations in current methods. Direct
observation can be costly, invasive, and unfeasible for longitudinal assessment of mobile screen use, while
self- and proxy-report struggle to sufficiently capture the intermittent bouts of screen use characteristic of child
screen use behavior. Current objective measures of screen time, passive sensing applications, are unable to
determine who is using the device, which is of particular concern when children are sharing devices with
parents and siblings. A strategy to address this critical shortcoming of objective measures of screen time is
using built-in sensors on mobile devices to determine who exactly is using the device. Mobile device sensors
(i.e., accelerometer, gyroscope, magnetometer, orientation, touch) have been widely used in behavioral
biometric authentication to identify the user while the user is interacting with the device. However, this
technology has not yet been applied to mobile screen use measurement to advance our current measures of
mobile screen use. To address this, Aim 1 will train machine learning models using mobile device sensor data
(accelerometer, gyroscope, magnetometer) to distinguish a target child, through which the most salient
features for child biometric authentication will be identified. Aim 2 will then evaluate model performance when
machine learning models are tested on a different sample of children during a structured screen time protocol.
To accomplish these aims, this study will complement and extend a current R01 (R01DK129215) that has an
overarching aim to strengthen the measurement of 24-hour movement behaviors in children using raw sensor
data (i.e., heart rate, accelerometry) from consumer wearable devices. This project will leverage sensor data
already collected as part of the sedentary block of the R01 protocol to address Aim 1 and will recruit a novel
sample of children from the free-living portion of the current R01 to address Aim 2. We will use the sensor-
tracking application, SensorLog, on the iPads and data from the built-in accelerometer, gyroscope, and
magnetometer sensors will be recorded continuously while the child interacts with the device. This project will
use advanced analytic techniques, including machine learning, to address these aims. Findings from the
proposed project will open a window of opportunity in child screen time research and offer an innovative
approach to objective screen time measurement. Long-term, the goal of this project is to improve the
longitudinal monitoring of screen time, which can then inform evidence-based guidelines for screen time in
children. As an NIH F31 predoctoral trainee completing this project, the following skills will be accrued:
implementing a validation study in children, using advanced analytical techniques, and disseminating research
findings in peer-reviewed publications and scientific presentations through a cross-disciplinary lens, all of which
will be instrumental in becoming an independent and productive research scientist.

Public health relevance
PROJECT NARRATIVE With the ubiquity of mobile devices, the accurate measurement of mobile screen use is critically important for understanding its impact on health-related outcomes in children. Objective measures of mobile screen use, or passive sensing applications, would be most optimal to capture intermittent bouts of screen use longitudinally, however, these applications do not lend themselves to capturing who is using the device at specific time points, introducing a critical limitation in mobile screen use measurement. The proposed study will evaluate the preliminary accuracy of machine learning models trained on sensor data from the built-in sensors on mobile devices, such as accelerometer, gyroscope, and magnetometer, to identify the unique child user of a device.